High-throughput disease modeling to uncover shared and unique characteristics among neurodegenerative diseases

Project Summary Neurodegenerative diseases (NDDs) present a large clinical and financial strain on the US healthcare system. We currently lack effective FDA approved therapeutics that halt or reverse the course of disease for many diseases in this class. Through modeling NDDs, we have begun to dissect the pathological impact of genes and proteins implicated in NDD development. We have discovered perturbations of core cellular processes such as protein folding and protein turnover are central to many NDDs. However, understandings of mechanisms and pathways governing disease development awaits for many NDDs. To approach this challenge, we propose a novel technology that using next generation DNA sequencing methods to examine multiple neurodegenerative disease models within a single experiment, thereby increasing throughput and limiting inter- experimental variation. To capture fundamental cellular perturbations imposed by each NDD model, we will characterize each model’s response to a wide range of genetic perturbations. Subsequent analysis of these data will reveal cellular pathways impacted by disease gene expression. We will apply this platform towards the study of Amyotrophic Lateral Sclerosis (ALS) and Frontotemporal Dementia (FTD), which occur on a clinical spectrum. Mutations in different genes implicated in ALS/FTD can bias patients towards either end of this spectrum. Additionally, there are many genetic variants implicated in ALS/FTD which remain functionally uncharacterized. The genes implicated in ALS/FTD have been shown to play a role in many cellular processes, including RNA metabolism, nucleocytoplasmic shuttling, and autophagosome maturation. Our technological platform will allow us to capture the scope of cellular responses to dozens of genes and alleles implicated in the development of ALS/FTD and also identify cellular targets for further study in human neurons. The goals of this project are to: leverage our multiplexed disease modeling platform on a genome-wide scale to identify of genes that enhance or ameliorate pathological consequences of genes implicated in ALS/FTD (Aim 1), and to harness these findings to validate potential therapeutic leads in iPSC cortical neurons (Aim 2).

Public health relevance
Project Narrative 1. Neurodegenerative diseases are debilitating to millions of people and remain largely untreatable, creating a significant demand for new therapeutics. 2. Dozens of misfolded proteotoxic proteins, each with familial variants, are implicated in neurodegeneration, but the common and unique features of how these proteins contribute to disease are currently not fully understood. 3. Here, we develop a new technology to efficiently conduct unbiased, genome-wide screening for dozens of neurodegenerative disease models within a single screen to identify potential therapeutic targets to be validated in iPSC derived neurons.